ANABOLIC EFFECTS OF GROWTH HORMONE IN CHRONIC RENAL FAILURE

To study the effect of daily injections of growth hormone on nitrogen balance, serum albumin and amino acid turnover in patients with chronic renal failure.